Non-synaptic function of Syngap1 in human neurodevelopmental disorders

SUMMARY
Advances in human genomics have dramatically accelerated our understanding of the genetics of
complex brain disorders, including autism spectrum disorders (ASD), schizophrenia (SCZ), and intellectual
disability (ID).
De novo mutations in SYNGAP1 have been reported in ASD, SCZ, and ID, indicating a role for SYNGAP1
in complex brain disorders. These mutations occur throughout the SYNGAP1 gene, which encodes multiple
isoforms, and likely affect different SYNGAP1 functions. Most studies of SYNGAP1 have been performed in
rodent models within the context of mature synapses and its role at early stages of brain development is largely
unknown, especially in humans.
Human brain organoids from pluripotent stem cells (PSCs) are emerging as a tractable model to reveal
genotype-phenotype correlations in a human cellular context. By leveraging cultures of cortical organoids, we
found for the first time the protein expression of SYNGAP1 in human radial glia progenitors (hRGP).
Mechanistically, we found that the SYNGAP1’s RASGAP domain is essential for cytoskeletal remodeling of
subcellular and intercellular components of hRGP. In addition, we discovered that SYNGAP1 regulates the
division mode of hRGP with haploinsufficient organoids exhibiting accelerated cortical neurogenesis. We
similarly observed an increased ratio of neurons to radial glial progenitors in an embryonic mouse model of
Syngap1 mutation, suggesting that Syngap1 controls the timing of cortical neurogenesis in vitro, in vivo, and
across species. Furthermore, we identified SYNGAP1 protein interactors with enriched neurodevelopmental
(NDD) risk factors in hRGP.
These findings lead to our proposal to determine i) the downstream effectors of Syngap1 in hRGP; ii) the
function of the SYNGAP1’s PDZ-ligand domain in controlling cytoskeleton remodeling in hRGP; iii) the impact of
SYNGAP1 mutations on the trajectory of distinct human cortical cell types; and iv) whether disruptions of
members of the SYNGAP1 Protein interaction network (PIN) can converge on dysregulation of human cortical
neurogenesis.
This work will be essential for reframing our understanding of the impairments in neural circuit function
observed in SYNGAP1 patients by connecting it not only with the well-known alteration in synaptic transmission,
but also with early developmental defects. It will also aid the stratification of SYNGAP1 mutations according to
their effects on the functionality of the SYNGAP1 PDZ-ligand and the RASGAP domain at early stages of human
brain development. Finally, by identifying the SYNGAP1 PIN in early brain development, we expect to discover
novel signaling hubs associated with NDD that converge on the dysregulation of human cortical neurogenesis
which will inform selection and screening of therapeutic targets.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it focuses on addressing the unexplored role of SYNGAP1 during human cortical neurogenesis. De novo mutations in multiple domains of the SYNGAP1 gene have been reported in ASD, ID, DD, ASD, SCZ, and epileptic encephalopathy. The proposed research is relevant to NIHM’s mission as it will aid stratification of SYNGAP1 mutations according to genotype-phenotype correlations and greatly advance our understanding of neurodevelopmental disorders that converge on the dysregulation of human cortical neurogenesis.